Unique targeting of PPARβ/δ regulation for cancer prevention and therapy

Project Summary: Precision approaches for inhibiting, preventing recurrence, or treating cancers remains a
top priority in the US. While different inhibitors have made significant improvements for these purposes (e.g.
immune checkpoint inhibitors, growth factor receptor inhibitors, etc.), it is clear that additional molecular targets
are needed to combine with these existing therapies due to the heterogeneity of cancers and the fact that
many cancers are resistant to different inhibitors. Thus, delineating new molecular mechanisms for
combinatorial approaches for more precision inhibition and therapy of cancer is of high significance. The
peroxisome proliferator-activated receptor-β/δ (PPARβ/δ) has great potential as a molecular target for
preventing and/or treating colorectal cancer (CRC). Typical ligands for PPARβ/δ increase and decrease target
gene expression. However, more selective, repressive PPARβ/δ ligands have recently been developed that
only repress gene expression rather than increase target genes. These selective repressive PPARβ/δ ligands
can markedly inhibit cellular events associated with cancer inhibition, progression and metastasis. There is no
dispute that selective, repressive PPARβ/δ ligands are effective anti-cancer molecules. These facts and
preliminary data provide strong support and rigor of the central hypothesis of this proposal that
repressing PPARβ/δ target genes by a selective, repressive ligand can modulate CRC and may be
targeted for precision approaches to inhibit/treat CRC. This hypothesis will be examined by 3 Aims. Aim 1
will include PK analysis of the selective, repressive PPARβ/δ ligand DG172 of tissue concentrations over time,
and phase I and phase II metabolism of the selective, repressive PPARβ/δ ligand in tissues, biofluids and
tumors. Aim 2 will determine the efficacy of the selective, repressive PPARβ/δ ligand DG172 to inhibit
tumorigenesis and stemness in novel orthotopic tumors models that utilize unique, genotypically variant human
cancer cell lines with genotypes that exhibit resistance to standard inhibitors used to treat CRC, and gain- and
loss-of-function models for PPARβ/δ. The mechanisms by which PPARβ/δ regulates stemness will also be
determined. For Aim 3, we will integrate genomic and metabolomic bioinformatic analyses to elucidate how
specific metabolic and tumor-promoting pathways that can be targeted by selective repressive PPARβ/δ
ligands to inhibit CRC progression and treat CRC. Data from Aim 3 will be made available to scientists by
developing a web-based platform to allow for systems analyses of PPARβ/δ-specific pathways that inhibit
CRC. Results from these studies will have a sustained impact as they will provide new PPARβ/δ-dependent
targets that might be combined with other inhibitors to develop more effective therapies, and prevent
recurrence, for CRC.

Public health relevance
Project Narrative: Despite significant advances in the prevention and treatment of CRC in the United States (1 of the top 3 cancer types in the U.S), there remains a need for new approaches and molecular targets to markedly reduce morbidity due to this disease. This proposal focuses on the use of a novel, selective compound that can repress the activity of a nuclear receptor, the peroxisome proliferator-activated receptor-β/δ (PPARβ/δ) for this purpose. The proposed studies will have high translational impact to fight this prevalent disease using selective modulation of PPARβ/δ transcriptional activity as a mechanism to prevent/treat CRC progression and may provide a new target for combinatorial strategies to effectively treat and/or prevent recurrence of this disease.